The Skull Bone Marrow Niche After Stroke

Outcomes and recovery after stroke are heavily influenced by the inflammation ensuing after ischemia. Among
the first responders, innate immune cells are particularly numerous and inflammatory. These cells, especially
neutrophils, have a life span on the order of hours and are produced and released by the hematopoietic
system just-in-time. Understanding choke points for immune cell supply to ischemic brain may provide
therapeutic opportunities to regulate CNS inflammation and stroke recovery. Recent work challenged the
prevailing dogma that skull bone marrow is merely one among many hematopoietic sites that contributes
leukocytes to the systemic circulation, from which they migrate into the ischemic brain. Rather, skull-produced
cells are surprisingly frequent in the CNS. We hypothesize that skull marrow exerts a critical influence on brain
health and post-stroke inflammation. This hypothesis is based on our discovery that skull hematopoietic niches
are directly connected to the CNS borders via hundreds of tiny channels through the skull cortex. Skull
channels transport leukocytes to meninges and, vice versa, transport CSF tracers to hematopoietic niches. In
all bones, including the skull, hematopoietic stem and progenitor cells (HSPC), which give rise to leukocytes,
follow the instructions of their microenvironment, that is, the hematopoietic niche they reside in. We
hypothesize that in contrast to remote long bones, skull marrow niche cells, through skull channels, sample
stroke-induced danger signals in the CSF. This, in turn, may have a site-specific effect on hematopoiesis, as
no other marrow location is in such close contact with CSF. In this application, we propose to examine the
post-stroke information transfer between the CNS and the skull marrow, which acts as a bespoke leukocyte
purveyor to the CNS.

Public health relevance
In this application, we will test the overarching hypothesis that the cerebrospinal fluid that drains via skull channels into the cranial bone marrow affects the skull hematopoietic niche after stroke. We will examine the importance of this outflow for activation of hematopoietic cells in the skull in mice with ischemic stroke.